GANESH (EMORY UNIVERSITY) - MCSP - HIT TO LEAD CHEMISTRY

In performance of work under this Task Order, the Contractor shall provide a full service facility
and staff who shall support a medicinal chemistry discovery program beginning at the Hit-toLead (HTL) Chemistry phase to develop structure activity relationship (SAR) analysis and
design, synthesis, in vitro absorption, distribution, metabolism, excretion and toxicology
(ADMET), computational chemistry/Computer Aided Drug Discovery (CADD), and compound
logistics of storage and shipping to support the Contributor Ganesh in developing a novel
therapeutic effective in treating post-seizure cognitive deficits. This will be achieved by
advancing the SAR/SPR of their small molecule heterocyclic starting compound utilizing their
assays and in vitro ADMET to identify novel, selective inhibitors of the target enzyme that are
directed at treating post-seizure cognitive deficits. Our drug discovery approach will be to
synthesize novel ligands based on the heterocyclic scaffold that are potent inhibitors.
Candidate molecules will undergo profiling to assess criteria specifically related to the
physicochemical properties of compounds in a therapeutic setting, including enzyme selectivity
and tests to determine potential interactions with key metabolic enzyme systems. The goal is
to advance the project to go/no go decisions with regard to progressing to the optional Lead
Optimization phase.

Public health relevance
Developing a therapy for post-seizure cognitive deficits.